Effect of Medicaid Accountable Care Organizations on Behavioral Health Care Quality and Outcomes for Children

PROJECT SUMMARY
One in six children aged 6-17 years had a behavioral health (BH) diagnosis in 2016, with estimates climbing to
more than one in four during the COVID-19 pandemic. Limited access to BH services has long presented
challenges for most children. Efforts to address the shortcomings of the specialty BH care system, such as
integrating BH care into pediatric primary care settings, and state programs that offer telephonic psychiatry
consultation to pediatricians, have helped improve care, but immense gaps in care and disparities persist.
Accountable care organizations (ACOs) incentivize care integration and population health, which promotes
community-health care linkages, care coordination, and interventions to address social determinants of health.
The innovative reform introduced by ACOs has the potential to improve BH care delivery, but their impact for
pediatric populations is largely unknown. Studies of adult populations suggest that ACOs with certain
organizational features (e.g., type of contract) may improve quality of care for chronic diseases but the few
studies of the impact of ACOs on quality of care and outcomes for children have not focused on this large,
high-risk population of children with BH disorders. This study will be the first to address this critical gap in
knowledge by taking advantage of the natural experiment taking place in Massachusetts (MA), a state with a
high prevalence of children with BH diagnoses. In 2018, MA, launched 17 new Medicaid ACOs with
heterogeneous organizational features (e.g., size; physician vs. hospital-led; age mix. We will leverage MA’s
innovative Medicaid ACO ‘experiment’ to address the following aims using mixed methods: 1) Evaluate the
impact of ACOs on BH care quality, outcomes, and disparities for Medicaid-insured children; 2) Discern how
ACO heterogeneity modifies ACOs’ effects on BH quality and outcomes; 3) Determine the relationship
between parent reported experience with their child’s Behavioral Health care and organizational features of the
Medicaid ACOs. Fundamental changes in healthcare are needed to address socioeconomic and racial/ethnic
disparities in BH care quality and outcomes for children in vulnerable populations. Our innovative mixed
methods approach to examining the association between exposure to a new heterogeneous group of Medicaid
ACOs and BH care and outcomes uses state-level administrative claims and survey data and key informant
interviews with ACO leaders and parents to begin to address this large gap in knowledge. This new information
is expected to benefit providers, payers, and policy makers responsible for the care of vulnerable populations
of children with BH disorders.

Public health relevance
NARRATIVE The prevalence of behavioral health (BH) disorders has climbed steadily among children in the U.S. over the past decade, disproportionately affecting children in lower income and minoritized populations. Access to appropriate diagnostic and treatment services for vulnerable populations is particularly challenging, but Medicaid accountable care organizations (ACOs) have the potential to address gaps in BH care for children in these populations. This study takes advantage of a natural ACO experiment taking place in Massachusetts to addresses gaps in knowledge about the effects of the accountable care ‘experiment’ on pediatric BH quality of care, utilization, outcomes, and disparities.